Admin-Core-001

This supplement award application focuses on strengthening the capacity of an African early stage investigator (ESI) to conduct high-quality research in sub-Saharan Africa and to generate context-appropriate evidence to address the burden of CaP in that region. This is with the aim of providing high-quality mentored translational cancer research to an African ESI and support the training of the ESI in developing professional competencies needed to establish a successful research career. To achieve this, we have worked with Dr Benson Nyambega (the ESI) to research project on investigating the Biological Determinants of Quality of Life Among Prostate Cancer Survivors in Kenya and Nigeria.